SD BRIN: BIOINFORMATICS CORE LIBRARY DATABASES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. One component of the bioinformatics core is enhancing the library information services available to network members. The Sanford School of Medicine Lommen Library plays a primary role by providing this literature and database access. Document delivery capability has been improved with BRIN funding by the installation of three workstations housing two Dell computers, one HP color laser printer, one HP b&w printer, and one Fujitsu color scanner. This allows more rapid retrieval and delivery of articles using Docline and Internet Ariel software. Support for online databases of scientific journals has been essential to both faculty and students at USD and at the partner undergraduate institutions.